Modulation of immune responses mediated by PorB from Neisseria gonorrhoeae

Antibiotic resistance in Neisseria gonorrhoeae has been rising over the last decade, leading the WHO and the
US CDC to label the emergence of antimicrobial-resistant N. gonorrhoeae a serious public health threat.
Development of a vaccine against N. gonorrhoeae is considered a critical step in prevention strategies to slow
the spread of antibiotic-resistant N. gonorrhoeae. However, individuals infected with N. gonorrhoeae remain
susceptible to repeat N. gonorrhoeae infection because they fail to develop effective protective immune
responses. Our research has found that the PorB porin, the most abundant protein antigen in outer membrane
vesicles (OMVs), suppresses the capacity of antigen-presenting dendritic cells to stimulate T cell proliferation
when treated prior to addition of T cells. This immunosuppressive effect likely contributes to immune evasion by
the bacteria and the failure to develop protective immune responses. Recently, N. gonorrhoeae infections have
fallen in countries or regions that deployed mass vaccination campaigns with vaccines against N. meningitidis
serogroup B made from OMVs, suggesting that these vaccines may offer partial cross-species protection against
N. gonorrhoeae. However, these OMVs have very high levels of PorB (and a related porin, PorA). We
hypothesize that because of the documented immunosuppressive effects of PorB, it is likely that these porins
limit the immunogenicity of OMV-based vaccines. One possibility is that the immunosuppressive effects of PorB
are due to its channel activity. To test whether decreasing or ablating the channel activity reduces the
immunosuppression mediated by PorB, we propose in Specific Aim 1 to use a structural model of PorB to
introduce cysteine (Cys) mutations at locations within the pore that would have a high likelihood of decreasing
or ablating channel permeation following modification by Cys-directed chemical reagents and crosslinkers. We
will establish the effectiveness of these different reagents to inhibit permeation by assessing channel activity in
lipid bilayers and in multilamellar vesicles using established protocols. Porin mutants that are readily inactivated
by sulfhydryl-directed reagents will be examined for their capacity to inhibit dendritic cell-mediated T cell
proliferation. To test whether reducing the level of PorB in OMVs impacts immunogenicity of vaccination with
OMV, in Specific Aim 2 we will create a strain of N. gonorrhoeae with regulated PorB expression. We will test
whether OMVs containing decreasing levels of N. gonorrhoeae PorB exhibit reduced capacity to inhibit dendritic
cell-mediated T cell proliferation and whether immunization of mice with these OMVs results in increased cellular
immune responses against N. gonorrhoeae. These experiments will serve as an important step in the future
development of more effective OMV-based vaccines.

Public health relevance
Project narrative Rising levels of antibiotic resistance in the bacteria as well as rising case numbers have created an urgent need to develop effective vaccines against Neisseria gonorrhoeae, and studies suggest that vaccines that contain bacterial outer membrane vesicles may provide partial protection against N. gonorrhoeae. A major protein antigen in outer membrane vesicles, PorB, has immune suppressive properties that may limit the immunogenicity of these vaccines. We propose to develop chemically inactivatable PorB proteins that can be used to generate outer membrane vesicles with improved immunogenicity.